Recovery Initiation and Management after Overdose (RIMO) Experiment

Emergency responders, including paramedics, fire fighters, and police, routinely come into contact
with individuals who have overdosed and play a critical role in administering naloxone to reverse
opioid-related overdose. However, mechanisms to link these individuals to medication-assisted
treatment (MAT) following an overdose are lacking. This study targets individuals in Chicago who
have received naloxone administered by first responders within the past week to reverse an overdose,
but who have not entered into MAT. Study participants will be recruited through partnerships with the
Chicago Fire Department (CFD) and Police Department (CPD); first responders will be trained to seek
consent from individuals who are alert and oriented after receiving naloxone for future contacts by
research staff as part of the naloxone standard protocol. Those who consent will be contacted and
screened for study eligibility within one week of naloxone administration; eligible participants will be
randomly assigned either to the control group, i.e., referral to MAT as usual, or to Recovery Initiation
and Management after Overdose (RIMO), an assertive linkage and recovery support intervention.
This intervention builds on an evidenced-based intervention for treatment linkage, monitoring, and
recovery support evaluated in 3 prior clinical trials by the study team.
The Phase 1 (R21) Pilot Aim is to: Adapt and pilot test an assertive intervention (RIMO) to link
individuals with opioid use disorders (OUD) whose overdose has been reversed by naloxone
administered by first responders to MAT. Forty individuals will be recruited from two communities in
Chicago with high rates of opioid-related overdose and naloxone administrations and will be randomly
assigned to receive either the “referral only” control or “RIMO”. Assessments will be completed at
baseline and outcomes collected from treatment records. Recruitment referral methods and RIMO will
be refined based on pilot study findings, focus groups with RIMO participants, and input from study
partners and advisory board, and the existing intervention procedures manual will be adapted.
The Phase 2 (R33) Experiment will use the study recruitment and RIMO procedures refined in
Phase 1 to recruit a total of 400 individuals and randomly assign them either to the referral only
control or RIMO. All participants will receive standardized assessments at baseline and 1, 3, 6, 9, and
12 months post-randomization. Phase 2 Study Aims are to evaluate RIMO’s:
1. direct effect on linkage to MAT, length of time on medication, dropout, and total days of MAT
2. direct and indirect (via MAT) effects on time to relapse, opioid use, and opioid-related overdose
3. direct and indirect (via MAT and opioid use) effects on opioid-related fatalities, OUD symptoms,
physical health, mental health and the cost of health care utilization.

Public health relevance
The RIMO intervention to be developed and evaluated in this study addresses the lack of effective methods for helping individuals to access MAT following an overdose reversal, the high volume of opioid overdoses in Chicago, and the inability of first responders to fill this gap. RIMO focuses on the challenges of recruiting individuals with opioid use disorders who are outside of treatment or other service systems and who are most in need of effective treatment linkage and engagement given their high risks of continued opioid use, overdose, and death. The potential public health benefits of the RIMO intervention are likely to yield increases in MAT participation and retention, reductions in opioid overdoses, and related fatalities.